Shared Resource Management

PROJECT SUMMARY/ABSTRACT (SHARED RESOURCE MANAGEMENT)
The Rogel Cancer Center (Rogel) Shared Resources (SR) provide technical expertise, state-of-the-art
technologies, data analysis, and training to meet Rogel members’ diverse scientific needs and facilitate research
directed toward Rogel’s scientific themes. Rogel manages thirteen SRs and is proposing two developing SRs in
this application. The SR management team, consisting of the Associate Director for SRs (ADSR), the SR
Administrative Manager, and the Rogel Director of Finance, oversee SR scientific quality, accessibility,
operations, budgets, and cost-effectiveness. Additionally, the management team works with Rogel members
through meetings and surveys to determine members’ future SR needs and to identify those services that are
no longer needed. As a member of the Rogel Senior Leadership Council, the ADSR, presents survey results and
SR data to senior leadership for discussion and decisions. Examples include successful progression of the Single
Cell Spatial Analysis developing SR and the Proteomics SR to full SRs; the discontinuation of computational
imaging in the newly renamed and refocused Preclinical Molecular Imaging SR; and proposed establishment of
the Liquid Biopsy and Epigenetics and Epigenomics developing SRs. The annual operating budget of the
combined Rogel-supported SRs is approximately ~$17.6M, of which only ~$1.9M is from the Rogel CCSG,
~$1.7M is from institutional support (i.e., Medical School, Rogel, and departments), and ~$14M is from other
sources (e.g., chargebacks, other grants, and contracts). Thus, the CCSG supports only ~10.8% of the overall
operating expenses of the SRs demonstrating strong leveraging of these robust and diverse institutional and
other funding mechanisms for Rogel SRs. During the project period, Rogel SRs successfully competed for S10
grants resulting in ~$3.9M toward the acquisition of new equipment. Rogel SRs serve all of the Rogel Research
Programs resulting in support of an average of 209 publications annually, with 30% in high impact journals. To
continue providing innovative and effective support to Rogel members we propose the following specific aims:
(Aim 1) Provide relevant, distinctive, and innovative expertise and services that enhance research capability and
members’ collaborations; (Aim 2) Ensure accessibility, stability, reliability, quality, accountability, and cost
effectiveness of SRs; (Aim 3) Forecast and meet future scientific SR needs of Rogel members. We will achieve
these aims through a combination of communication with users and SR staff; critical evaluation of SR-relevant
metrics; and input from senior leadership, Program leaders and advisory boards. Through these activities, Rogel
SRs will continue to provide services that are critical to Rogel member research and to the Rogel mission.